PREMIUMS AND EMPLOYEE CHOICE OF HEALTH INSURANCE

The purpose of this project is to examine data from the State of Minnesota Employee Health Benefits Plan and other Twin Cities employers to determine: a. the effect of out-of-pocket premiums on the consumer's choice of health plan, and b. the effect of a level-dollar employer contribution to premiums on the level and rate of growth in premiums for health plans offered by an employer. The project uses time series data from a sample of Twin Cities employers.